Evaluating Telemedicine-Related Opioid Use Disorder (OUD) Services in Underserved Populations: A Comparison of Waiver and Post-waiver Periods

This project seeks to identify factors predictive of access to OUD-related telemedicine in Houston’s
underserved communities, and the impact of OUD-related telemedicine on treatment initiation and
retention. The proposed research recognizes that black and Hispanic communities in Texas are at a triple
disadvantage for OUD treatment considering the intersectionality of state-specific access to care
barriers, cultural barriers, and the digital divide. To narrow treatment disparity gaps in these
communities, it is important to include them in the research process that contributes to the
development of a culturally-informed, framework to inform a pilot telemedicine champion program to
advocate for, and address barriers to telemedicine use in this population. Utilizing a mixed-methods
research design, the proposed work provides a multi-faceted approach to (1) better understand
experiences, barriers, and facilitators, with accessing OUD-related telemedicine for treatment initiation
and maintenance during waiver vs non-waiver eras, (2) develop a community-informed framework for
OUD-related telemedicine, and (3) pilot an OUD-related telemedicine champion program that will serve
as a model to raise awareness of, and proactively address disparities in treatment uptake and retention.

Public health relevance
The past three years with the COVID-19 pandemic stimulated the rapid expansion of telemedicine to bridge access to care gaps for OUD treatment. But the use of technology is not without challenges. This pilot proposal seeks to identify factors predictive of access to OUD- related telemedicine in Houston’s underserved communities, and the impact of OUD-related telemedicine on treatment initiation and retention.